IGF::OT::IGF NS IDIQ: OPERATIONS AND TECHNICAL SUPPORT (OTS) FOR THE FREDERICK NATIONAL LABORATORY FOR CANCER RESEARCH (FNLCR), A FEDERALLY FUNDED RESEARCH AND DEVELOPMENT CENTER (FFRDC)

OPERATIONS AND TECHNICAL SUPPORT (OTS) FOR THE FREDERICK NATIONAL LABORATORY FOR CANCER RESEARCH (FNLCR), A FEDERALLY FUNDED RESEARCH AND DEVELOPMENT CENTER (FFRDC)